EFFECT OF IRBESARTAN IN HYPERTENSIVES WITH TYPE II DIABETES AND NEPHROPATHY

The goal of the study is to determine whether irbesartan, an angiotensin II receptor antagonist, will increase the time to doubling of serum creatinine, end-stage renal disease or death compared to placebo or amlodipine in hypertensive patients with diabetic nephropathy.